Exploring synthetic lethality with a novel very high energy electron FLASH radiation beam

ABSTRACT: Radiation therapy is a necessary component of current treatment for many brain tumors.
Radiation therapy leverages a therapeutic ratio in which tumor cells suffer radiation damage and die, while
normal brain cells repair radiation damage and are less negatively affected. Improvements in the therapeutic
ratio are badly needed both to improve brain tumor cure probability and limit risk for radiation effects on the
normal brain such as radiation necrosis and neurocognitive dysfunction. Efforts to widen the therapeutic
window for radiation therapy of brain tumors have included chemical approaches to combine RT with drugs
intended to increase tumor cell radiosensitivity, or normal cell radioresistance, however, to date, few effective
therapies have emerged. Recently, advances in physics have produced “ultra-high” rates of radiation dose
delivery (termed “FLASH-RT”). Compelling reports point to normal tissue protection with FLASH-RT dose
delivery, however the molecular mechanism of FLASH-RT is largely unknown. Interestingly, ferroptosis cell
death mechanisms have been implicated. Our multidisciplinary collaborative team has leveraged
complementary expertise to develop resources and preliminary data to improve the brain tumor radiation
therapy therapeutic window through both chemical and physical means. We have created a unique
experimental platform with two novel components: 1) A highly tunable, very high dose-rate electron FLASH-
RT beam provided by the High Intensity Gamma-ray Source (HIGS) at the Triangle Universities Nuclear
Laboratory (TUNL) and 2) an Organotypic brain slice culture (OBSC) assay platform that allows interrogation of
both tumor and normal brain tissue cells in an elevated-throughput dry-culture system highly amenable to
experiments with both standard RT and our unique FLASH-RT beam. Encouragingly, preliminary data in our
OBSC system shows that ATM kinase inhibition seems to protect neurons from ferroptotic death. To achieve
our long-term goal to widen the therapeutic window, we propose two hypotheses: 1) ATM inhibition can widen
the radiation therapeutic window for brain tumors by sensitizing tumor cells and protecting neurons especially
under FLASH-RT conditions, and 2) Cancer cells depend on adaptations to maintain rapid growth in the brain,
and these adaptations can be exploited to enhance tumor cell killing. We will test these hypotheses with the
following aims: 1) Optimize HIGS-FLASH beam parameters (dose, dose-rate, targeting) for enhanced
metastatic brain tumor cell kill with maximal protection of normal brain under normal and ATM inhibition
conditions. 2) Test genetic targets for radiation sensitization in glioblastoma cells under standard and FLASH-
RT dose rates in the OSBC system. We expect that this project will elucidate cytotoxic mechanisms of both
standard and FLASH-RT and generate highly-translatable drugs and drug targets to widen the therapeutic
window for brain tumors. If successful, this project will expand to larger screening sets and additional brain
tumor types, with in vivo model validation.

Public health relevance
NARRATIVE: Radiation therapy (RT) is commonly used to treat brain tumors, however improvements are needed to make RT more effective against tumor cells and/or less damaging to normal brain cells. Our team of physicists, biologists and radiation oncologists has developed a platform to test genes and drugs as well as new types of radiation (ultra-high dose rate radiation, or FLASH-RT) to improve radiation therapy for brain tumors. This proposal describes how we will use this platform and our existing data to test combinations of standard and FLASH-RT with drugs targeting the ATM gene and other genes to improve treatment for brain tumors.